Social and Behavioral Sciences Core

PROJECT SUMMARY – Social and Behavioral Sciences Core
The Social and Behavioral Sciences (SBS) Core is the primary resource for university-wide scientific consultation
on the design and conduct of interdisciplinary social and behavioral studies related to HIV. The mission of the
Core supports NIH Priority areas for HIV/AIDS research, including reducing the incidence of HIV infection,
developing new therapies to optimize engagement and retention, and addressing HIV-associated comorbidities,
coinfections, and complications. In the most recent funding cycle, the Core served 71 NIH-funded research
projects from 36 Duke investigators, with steady growth on both of these metrics during each year of the funding
cycle. In the last 3 years, 72% (n=21) of grants that were peer reviewed by the SBS Core were funded. The Core
provided services related to preparing for grant submissions, research implementation, networking, community
collaboration, and mentorship of new investigators. The SBS Core proposes to capitalize on its successes in the
last five years by continuing to support investigators to develop their diverse independent research portfolios,
and improving the quality and breadth of SBS research at Duke to address the global and regional HIV
epidemics. This will include a specific focus on supporting early-stage investigators, those new to HIV research,
and investigators from historically underrepresented groups. The SBS Core will continue to collaborate with other
CFAR Cores, the CFAR scientific working groups (SWGs), and the broader community to expand focus on the
three NIH Priority areas. The SBS Core has four Specific Aims: 1) Provide expertise in the social and behavioral
sciences in order to advance research across the HIV/AIDS care cascade and prevention continuum. 2) Enhance
the scientific rigor and potential impact of social and behavioral HIV/AIDS research by providing consultations
on research methods and intervention approaches. 3) Build the individual and collective capacity of SBS Core
users at Duke University by attracting and supporting early stage investigators and investigators new to HIV,
providing mentorship and training, and facilitating interdisciplinary collaborations both within Duke and with other
CFARs. 4) Expand the reach and impact of SBS studies by linking SBS Core users to appropriate community
partners and assisting in the implementation and dissemination of findings to stakeholder and scientific
communities. Through these aims, the Core will continue to provide scientifically sound, individualized services
to a large number of investigators, sharing expertise in research, and maintaining high success rates of NIH
funding for Core users. The Core's efforts will add value and provide economy of scale to existing NIH-funded
HIV research at Duke, and will support research efforts to advance science and practice across the continuum
of HIV prevention and care.